Investigating a Novel Cellular Therapy to Prevent and Treat Acute Antibody Mediated Kidney Transplant Rejection

Project Summary
Transplant specific antibodies (alloantibodies) are known to mediate acute antibody-mediated rejection (AMR)
after kidney transplant and also negatively impact long-term kidney allograft survival. Our group discovered a
novel regulatory CD8+ T cell subset which suppresses alloantibody production posttransplant. We refer to
these antibody suppressor CD8+ T cells as CD8+ TAb-supp cells and have developed a strategy to enhance their
in vivo development, distinguish their phenotype from other alloprimed CD8+ T cells and assess their in vitro
and in vivo function. In Aim 1 we will perform pre-clinical studies to investigate the efficacy of CD8+ TAb-supp
cells to prevent the development of de novo post-transplant alloantibody and AMR after kidney transplant using
a murine model of kidney transplant which reproduces the histopathology of AMR observed in human kidney
transplant recipients. In Aim 2 we will perform pre-clinical studies to investigate the efficacy of adoptive cellular
therapy with CD8+ TAb-supp cells to treat AMR and prolong kidney transplant function and survival. Our research
team assembles investigators with expertise in clinical transplantation, transplant immunology, microsurgery
and kidney histopathology.

Public health relevance
Project Narrative This project investigates novel cellular therapy with antibody-suppressor CD8+ T cells to inhibit the production of anti-donor antibodies after kidney transplantation and to treat acute alloantibody mediated kidney transplant rejection. Results from these studies also have relevance for modulation of antibody production or mitigation of antibody mediated tissue damage for conditions other than transplant (such as in humoral immunity to infectious pathogens, autoimmunity, anti-tumor immunity and vaccination strategies).